Regulation of Fracture Healing by Macrophage-Derived Wnt Ligands

PROJECT SUMMARY
Fracture healing is a complex bone healing process regulated by various classes of cells and signaling
mechanisms. Of these, Wnt signaling has long been known to be critically important in directing the differentiation
of mesenchymal stem cells (MSCs) into osteoblasts during bone healing. However, the source of these Wnt
ligands is not known. Recently, a body of literature has arisen finding both beneficial and detrimental effects of
macrophage-derived Wnt ligands on the regeneration of other tissues (liver, kidney, heart, and intestine), often
by their modulation of progenitor cell behavior. As macrophages have been well-characterized as orchestrators
of healing, their use of Wnt signaling to regulate tissue regeneration is unsurprising. However, no studies have
yet identified the contribution of macrophages to Wnt signaling during fracture healing. Interestingly, recent
unpublished data suggests that macrophages represent a major source of Wnt ligands during bone healing and
underscore the importance of macrophages in driving this process. In the work proposed here, the expression
of Wnt ligands by macrophages will first be measured, as well as the cells targeted by Wnt ligands, during fracture
healing. Then, Wls, the gene encoding a necessary Wnt ligand trafficking protein, will be deleted in Csf1r-
expressing cells (monocytes and macrophages), inhibiting the secretion of all Wnt ligands by these cells after
induction of Cre recombinase with tamoxifen. Following deletion of macrophage Wls, the consequences of loss
of macrophage-derived Wnt ligands will be characterized during the inflammatory, soft callus, and hard callus
phases of healing. Appropriate transition through these phases, and ultimately successful healing, will be
evaluated using qPCR, flow cytometry, micro-computed tomography, and histology. Finally, the mechanism of
Wnt trafficking to MSCs, and the consequences of their effects on MSC behavior, will be evaluated through in
vitro co-culture experiments. The studies defined in this proposal will elucidate the importance of macrophage
Wnt ligands on bone healing and potentially identify Wnt signaling as a targetable pathway to enhance successful
osseous healing.

Public health relevance
PROJECT NARRATIVE Despite the relatively high success rate of fracture healing in healthy individuals, success may be complicated by a variety of factors, leading to non-union or malunion. As macrophages, a class of immune cell, are known to regulate healing in various tissues, understanding the entirety of their contributions to fracture healing may aid in the identification of novel targetable or manipulatable pathways within the immune system to prevent complications or enhance bone healing. Here, we propose to explore the influence of macrophage-derived Wnt ligands, a secreted signaling molecule, on osseous healing by exploring their functions in injured bone and by identifying the consequences of their absence.